CARP-1: A Potential Therapeutic Agent for Breast Cancer

Development of new and improved strategies for triple-negative breast cancer (TNBC) treatment is urgently
needed since molecular complexity of TNBC together with therapy-associated side effects and emergence of
drug-resistance often limit effectiveness of current therapies. CARP-1/CCAR1 is a ubiquitous, phospho-protein
that can induce proliferation and apoptosis through multiple mechanisms. CARP-1 transduces chemotherapy
(adriamycin, etoposide, or Iressa)-dependent inhibitory signaling, and co-activates Adriamycin (ADR)-induced
p53. CARP-1 also co-activates cell-cycle regulatory anaphase-promoting complex (APC/C) E3 ubiquitin ligase
and steroid/thyroid receptors. Here we report that CARP-1 interacts with ERKs, and binds with NEMO (NF-B
Essential Modulator; NF-B-activating kinase IKK subunit ). Our preliminary and published studies revealed
that ADR induced CARP-1 threonine627 phosphorylation, ERK activation, and canonical NF-B pathway that
involved NEMO-CARP-1 binding. Importantly, inhibition of NEMO-CARP-1 binding diminishes NF-B activation
(noted by phosphorylation of p65/RelA) by ADR but not by TNFα, interleukin (IL)2, or EGF. Further, SNI-1, a
novel SMI of NEMO-CARP-1 binding, enhances ADR or Cisplatin inhibition of TNBC cells, diminishes levels of
genotoxic stress (ADR or Cisplatin)-induced pro-inflammatory cytokines TNFα and IL8. SNI-1 enhances TNBC
growth suppression by ADR or Cisplatin in vivo in 4T1 syngeneic tumor model.
Hypothesis: DNA Damage-inducing drugs (ADR, Cisplatin) activate CARP-1-mediated canonical NF-B and
ERK pathways. The rationale for this hypothesis include our preliminary and published studies that indicate
inhibition of therapy-induced, canonical NF-B activation by disruption of NEMO-CARP-1 binding enhances
efficacy of ADR and Cisplatin in vitro and in vivo. Moreover, ADR also induces CARP-1 phosphorylation and,
since genotoxic therapy also activates ERKs, targeting of NEMO-CARP-1 binding together with ERK inhibitors
will result in greater tumor suppression by ADR or Cisplatin. Thus, targeting of CARP-1/NEMO binding could
permit us to overcome chemo-resistance in TNBCs without affecting other central functions of NF-B induced
by TNFα, IL2, and/or EGF signaling necessary for host tissue homeostasis. We will conduct following three
aims to test our hypothesis.
Aim 1: To define role of CARP-1 in genotoxic chemotherapy-induced canonical NF-B survival pathway. SNI-1
inhibits therapy-induced NEMO phosphorylation. We will elucidate how SNI-1 inhibits DNA damage-induced,
NEMO phosphorylation and canonical NF-B pathway.
Aim 2: To investigate mechanism(s) by which CARP-1 interacts with ERKs. We will determine how targeting of
ERKs in combination with SNI-1 enhances efficacy of genotoxic chemotherapy.
Aim 3: To demonstrate targeting of CARP-1/NEMO-dependent canonical, NF-B signaling by water-soluble
SNI-1 alone or coupled with targeting of ERKs by therapeutics currently in clinical trials/use, will result in
superior TNBC tumor kill by genotoxic chemotherapy in vivo.
Potential Impact on Veterans Health Care: The proposed studies will yield valuable knowledge of molecular
mechanisms of action of genotoxic chemotherapies (ADR and Cisplatin) to permit effective treatment of
TNBCs and their drug-resistant counterparts. Our discovery of SNI-1 and its potential to enhance efficacy of
TNBC therapies to overcome therapy-induced resistance will have translational impact and are expected to
facilitate development of novel and effective strategies to combat hard to treat breast cancers that will benefit
female VA workforce, contribute to Veterans Health Care and further the VA mission.

Public health relevance
We are proposing to continue our studies investigating molecular mechanisms of human breast cancer (HBC) growth regulation by a cellular phospho-protein CARP-1/CCAR1 that was previously identified and characterized by us. CARP-1 regulates chemotherapy (adriamycin or iressa)-dependent growth inhibition of HBC cells. We recently identified a novel, Adriamycin (ADR)-induced mechanism of apoptosis that requires CARP-1 binding with H2AX. In addition, we have found CARP-1 regulates canonical NF-κB in the presence of ADR. CARP-1 binds with IKKγ (aka NEMO). A novel, small molecule inhibitor (SMI) of CARP-1/NEMO binding enhances ADR efficacy and sensitizes HBC cells to ERK-targeting therapeutics. Thus, knowledge of the mechanisms of HBC growth suppression by SMI that targets CARP-1/NEMO binding could be exploited to enhance ADR efficacy and effectively target ADR-resistant breast cancers in the clinic.